PHASE I FAST TRACK TOPIC 461 CONFORMABLE SCINTILLATOR ARRAY FOR IN VIVO DOSIMETRY DURING RT

Real-time, optical imaging of dose and dose rate on the surface of a patient can be achieved with a new product methodology: a deformable scintillator array placed on the patient’s surface for imaging by a camera system mounted in the radiotherapy treatment room for both conventional and ultra-high dose rate (UHDR) deliveries. Additionally, a flat panel style scintillator could be placed for pre-treatment quality assurance (QA) of complex patient deliveries, specifically UHDR treatments. The seamless electronic readout of dose and dose rate delivery via high resolution, fast imaging, provides a treatment verification system that eliminates the labor and time required of existing in vivo dosimetry tools and that fills a gap in UHDR dosimetry. The goal of this project is to advance the development of scintillation imaging as a
reliable tool for dose and dose rate validation of FLASH and conventional radiotherapy beams. Phase I of this proposal is aimed at building and characterizing a prototype system; the Phase II proposal seeks to further advance the prototypes developed and tested in Phase I towards clinical implementation, via batch manufacturing, software upgrades, user testing, and the first clinical install.